AFFINITY REAGENTS FOR THE IMMUNE SYSTEM OF GUINEA PIGS

The goal of this project is to generate rabbit monoclonal antibodies to selected five biomarkers of immune cells in order to study immune response in guinea pigs.